Neurocognitive Consequences of Intermittent Hypoxia

PROJECT SUMMARY
Sleep apnea is a respiratory disorder that causes chronic intermittent hypoxia throughout the sleep cycle.
Neuroimaging studies indicate that the hippocampus is particularly vulnerable to injury in sleep apnea. In
addition to the involvement of this brain structure with spatial and recognition memory, hippocampal activity is
coupled to and exerts influence on peripheral chemoreflexes and respiratory patterns. Thus, along with its
cognitive effects, the neurophysiological changes in the hippocampus may contribute to the development of
cardiovascular disease, the increased risk for stroke that occur with untreated sleep apnea. As the duration of
untreated sleep apnea persists, the severity of the condition increases, as does the risk of developing
increasingly significant cognitive deficit. We hypothesize that chronic intermittent hypoxia caused by sleep
apnea triggers reactive oxygen species signaling, resulting in duration-dependent changes to hippocampal
neurophysiology and, in turn, causing progressive degradation in hippocampal-based cognition. We test this
hypothesis in a rodent model of sleep apnea in which animals are exposed to different durations of chronic
intermittent hypoxia. We examine the resulting effects on hippocampal neurophysiology and neurogenesis,
focusing on principal neurons involved in learning and memory pathways. In addition to dissecting the role of
reactive oxygen species signaling in cognitive changes, we explore the mechanistic origin of this signaling and
the potential interaction between cardio-respiratory organs (i.e., carotid bodies) and the hippocampus. The
mechanistic insights gained from this work will inform the development of more effective therapies to prevent,
or fully reverse, cognitive decline in a condition that affects the quality of life for many Americans.

Public health relevance
PROJECT NARRATIVE Sleep apnea is a common clinical condition that produces intermittent hypoxia, causing cardio-respiratory dysfunction and cognitive deficit. This project examines the impact of intermittent hypoxia on the hippocampus, a brain structure involved in both cognition and cardio-respiratory function. We propose to track intermittent hypoxia-induced changes in hippocampal neurophysiology, the generation of adult born neurons, and cognitive performance.